Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT
The deployment of appropriate analytic techniques and careful data management are an essential component
for all Roswell Park Ovarian Cancer SPORE projects. The Biostatistics and Bioinformatics Core (Core C) will
ensure that essential biostatistics and bioinformatics supports and resources are readily available to all SPORE
research projects. The goals of the Core are to improve the productivity of the Individual Research Project
investigators, reduce the barriers for access to analytic expertise, maintain high standards for data collection and
management, design and perform rigorous analytical strategies, and foster a collaborative and supportive
research community.
The Biostatistics and Bioinformatics Core will assist basic, translational and clinical researchers of the SPORE
with proper formulation, refinement and execution of study objectives by applying the appropriate biostatistics
and bioinformatics analyses, and providing the appropriate interpretation of their results, in terms of both
strengths and limitations. We will ensure a priori that Developmental Research Program and Career
Enhancement Program projects are feasible from a biostatistical and bioinformatics perspective. The
Biostatistics and Bioinformatics Core will ensure that appropriate data are collected; the data are of the highest
quality and meet regulatory standards for privacy; and the data are those required to answer a study question,
necessary for administrative reporting, needed to establish protocol compliance, and/or will be included in a
manuscript. We will prepare Data Safety Monitoring Board reports and post clinical trial results to clinicaltrials.gov
in a timely and compliant manner and ensure compliance to NIH policy and assist with data sharing of SPORE
data via the NCI Cancer Research Data Commons infrastructure and similar NIH-designated data repositories.
The Biostatistics and Bioinformatics Core will develop and implement new and novel statistical and bioinformatics
methodology and the related software as needed to address all study objectives. We will implement software
solution and best practice to boost robust and reproducible research. Our proposed Biostatistics and
Bioinformatics Core will capitalize on a number of existing, well-functioning, NCI-funded units housed within the
Roswell Park Department of Biostatistics and Bioinformatics.

Public health relevance
Project Narrative The deployment of appropriate analytic techniques and careful data management are an essential component for all Roswell Park Ovarian Cancer SPORE projects. The Biostatistics and Bioinformatics Core will ensure that the essential biostatistics and bioinformatics support and resources are readily available to all SPORE research projects.